Vesicle Translocation and the Metabolic Syndrome

Abstract
The regulation of glucose homeostasis is a complex process, which is disrupted in disease states such as type
2 diabetes. Insulin is the primary hormone that regulates glucose homeostasis. Insulin stimulates glucose
uptake in muscle and fat by mobilizing intracellular vesicles containing GLUT4 glucose transporters, which fuse
and insert GLUT4 at the cell surface. Impairment of this process results in insulin resistance and contributes to
the development of diabetes. Therefore, to understand the pathogenesis of metabolic disease, it is necessary
to understand the molecular mechanisms that control GLUT4 trafficking, and to understand how this trafficking
is modulated by insulin and disrupted in insulin resistance. Previous work identified the TUG protein as a
major regulator of GLUT4 trafficking and glucose uptake in muscle and fat cells. The data support a model in
which TUG mediates the intracellular retention of GLUT4 in specific vesicles within unstimulated cells. Insulin
triggers TUG endoproteolytic cleavage to mobilize these vesicles to the cell surface. TUG cleavage
coordinates glucose uptake with other physiologic effects, resulting from the action of proteins that co-traffic
with GLUT4, as well as from action of the TUG C-terminal product to modulate gene expression. In insulin
resistant individuals, impairment of this mechanism may contribute to the metabolic syndrome and obesity.
Yet, it remains unknown how this mechanism is affected in insulin resistance, whether attenuated TUG
cleavage causes insulin resistance in muscle, or whether TUG cleavage participates in exercise-stimulated
glucose uptake. As well, the molecular mechanisms by which intact TUG retains GLUT4 in an insulin-
responsive pool of vesicles are not understood. To address these questions, two Aims will be undertaken.
Aim 1 will characterize insulin resistance and glucose homeostasis in mice with muscle-specific disruption of
TUG or of TUG endoproteolytic cleavage, and will study the potential role of this pathway in exercise-induced
glucose uptake. Aim 2 will study molecular mechanisms by which TUG traps GLUT4-containing vesicles in an
insulin-responsive pool, and by which this process may be altered in insulin-resistant states. We anticipate
that, together, these studies will result in an improved understanding of glucose metabolism and energy
expenditure, with implications for the prevention and treatment of diabetes and the metabolic syndrome.

Public health relevance
Narrative This project will study the molecular mechanisms by which insulin stimulates glucose uptake in muscle and fat cells, and how these mechanisms are affected in insulin resistant states such as type 2 diabetes. Improved understanding of these mechanisms may lead to new approaches to prevent or treat diabetes and obesity.